AD Gene Discovery: Exome Chip, New Endophenotypes & Functional Studies in CHARGE

DESCRIPTION (provided by applicant): This competitive renewal grant application seeks to continue a collaboration that used genome-wide association data in large, prospective epidemiological cohorts, the Cohorts for Heart and Aging Research in Genomic Epidemiology (CHARGE), with >2-6 decades of risk factor, dementia, AD, MRI and cognitive endophenotype data in >30,000 persons to identify new genes/loci underlying the risk of Alzheimer's disease (AD). It produced >50 publications, helped identify 9 novel loci for AD (BIN1 & EPHA1 first reached genome-wide significance in a CHARGE-lead publication), and 8 for AD endophenotypes. CHARGE helped found the International Genomics of Alzheimer Project (IGAP) and established collaborations with >25 cohorts/ consortia such as the Enhancing Neuro Imaging through Meta-Analysis (ENIGMA) consortium. However, genes identified to date collectively explain <35% of the observed AD heritability of 60-80%. The missing heritability could be partly explained by multiple low-frequency or rare genetic variants that can be detected cost-effectively via analysis of exome chip (EC) data now available in the original CHARGE and in 4 additional cohorts (the CHARGE-Plus sample: n=45,910, ~4058 with AD). In this application we propose the following: Aim 1: To use EC data to search for rare genetic variants related to incident clinical AD, and to AD endophenotypes. We have shown that GWAS of AD endophenotypes, e.g. hippocampal & total brain volumes, verbal memory can identify novel loci implicated in brain aging, and biological pathways underlying AD. We propose to use EC data to search for rare variants related to these established AD endophenotypes. Aim 2: To understand preclinical AD, the stage of early pathological changes 1-2 decades before clinical AD, during which AD is likely most amenable to intervention, we propose GWAS and EC analyses of emerging novel, sensitive MRI endophenotypes, cognitive and circulating biomarker (plasma β-amyloid and clusterin) data in the entire CHARGE-Plus and in younger cohorts aged 30-65 years. Aim 3: To better understand the biology, epidemiological and public health significance of the identified genes we will study gene-gene interactions between known and novel loci, and gene-environment interactions both targeted (interaction of loci from Aims 1&2 with midlife cholesterol and BMI), and genome-wide. The CHARGE cohorts, with premorbid data on mid-life exposure to a wide-range of environmental covariates, are uniquely positioned to study such interactions and permit analyses of other covariates when indicated. Aim 4: Finally, we will explore the biology of the identified variants using bio-informatics annotation databases created in CHARGE, available systemic and brain mRNA, miRNA, methylation data (n~8000 & 750, respectively), hippocampal neuronal expression in autopsy brains and in Drosophila tau & β-amyloid models. We seek modest analytic resources to leverage existing phenotypic and genotypic data worth millions, to discover new AD genes and potentially novel prevention and treatment approaches for AD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease (AD) is a major public health burden with no known prevention or treatment, but identifying new AD genes can uncover new biological pathways leading to novel treatments. We assembled an international collaboration of cohort studies and searched for common genetic variants causing AD leading to the identification of 9 novel genes for AD, 8 for MRI and cognitive function markers of AD; we propose to expand our studies to seek rare genetic variants for AD using exome chip data on 45,000 persons, 4000 with AD. We will also explore the genetics of preclinical AD in the 40,000 without clinical disease by studying newer, sensitive MRI markers and gene-environment interactions and study the expression in humans and function in Drosophila for the novel genes we find. __SpecificAimsTextDelimiter__ SPECIFIC AIMS (Renewal of R01 AG033193: Collaborative GWAS of AD and Related Endophenotypes) We seek to renew our ongoing grant on the genetics of Alzheimer's Disease (AD) that partly funded the formation of the international Cohorts for Heart and Aging Research in Genomic Epidemiology (CHARGE) consortium and enabled the development of a neurology phenotype working group within CHARGE (neuroCHARGE). The core CHARGE includes 5 large prospective cohorts,1 the Aging Gene-Environment Susceptibility - Reykjavik Study [AGES],2 the Atherosclerosis Risk in Communities [ARIC] Study3, 4 the Cardiovascular Health Study [CHS],5-7 the Framingham Heart Study [FHS]8-11 and the Rotterdam Study [RS].12 In the current grant period we had over 50 publications that identified 9 novel loci for AD (2 of these, BIN1 and EPHA1 were first described in a CHARGE-led publication), and 8 novel loci underlying AD endophenotypes.13- 37 neuroCHARGE helped found new consortia such as the International Genomics of Alzheimer Project (IGAP) and has formed productive collaborations with over 25 other cohorts and consortia such as the Enhancing Neuro Imaging through Meta-Analysis (ENIGMA) consortium. Genome-wide association studies (GWAS) have identified 9 late-onset AD (LOAD) genes in addition to APOE. 23, 35, 38-40 However these genes collectively explain <35% of the observed heritability of 60-80%.41 Some of the missing heritability may be explained by multiple low-frequency or rare variants. The recently released exome chip (EC) contains low-frequency and rare coding variants identified in 12,000 persons who had whole exome sequencing and permits low-cost genotyping of these variants. EC data are now available in an expanded CHARGE-Plus sample (5 core CHARGE studies + 4 additional cohorts, n=45,910, 4058 AD).42 We have shown that GWAS of several AD endophenotypes, such as hippocampal volumes, can identify novel loci implicated in structural and cognitive brain aging, and in biological pathways underlying AD.13-19 We will use EC data to search for rare variants related to these established AD endophenotypes. We also propose to extend our study to novel endophenotypes and study these in younger persons aged 30-65 years who are more likely to have Preclinical AD, the stage of pathological AD changes without clinical correlates that is likely most amenable to intervention. To better understand the biology, epidemiological and public health significance of the identified genes so that these genetic discoveries can be translated into prevention and treatment approaches, we seek to extend our studies to include gene-gene (GG) and gene- environment (GE) interactions. The CHARGE cohorts, with premorbid data on mid-life exposure to environmental covariates, are uniquely positioned to study such interactions. Finally, we will use the rich bioinformatic and expression resources created within CHARGE, and established collaborations with laboratory investigators to rapidly and iteratively explore the biology of the identified variants. We propose the following Specific Aims: Aim 1a: To use EC data to identify low-frequency and rare exonic variants underlying (1.a-i) the risk of AD and (1.a-ii) established AD endophenotypes, both MRI (e.g. hippocampal and total brain volumes, n~12,000) and cognitive (e.g. verbal memory, n~30,000) in the CHARGE-Plus samples. Aim 1b: To confirm findings from Aim 1a with in-silico replication using EC data that will become available in IGAP (for AD, n~57,000), ENIGMA (MRI, n~10,000) and other collaborating cohorts (Cognition, n~20,000). Aim 2a : To use GWAS & EC data to identify genes/loci underlying preclinical AD by searching genome- wide for novel associations, and examining the effects of known AD loci (from prior publications and Aim 1) on (2.a-i) sensitive, novel MRI endophenotypes (n~12,000, e.g. 'AD signature' patterns of MRI regional cortical atrophy, fractional anisotropy across regions of interest),43-45 (2.a-ii) lower global cognitive function (~30,000) and (2.a.iii) plasma β-amyloid (n~25,000) and clusterin (n~8000) in all of CHARGE-Plus, and Aim 2.b: To repeat the analyses from Aim 2.a. in younger cohorts, (n=9500, age 30-65 yrs): the FHS 3rd generation, RS 3rd wave and the Coronary Artery Risk Development in Young Adults [CARDIA] study. Aim 3: To test for targeted and genome-wide GE and GG interactions (3.a) To test for GE interactions between the loci/variants identified in Aims 1 & 2 and (i) serum cholesterol, (ii) body mass index measured at ages 45, 55 and 65 years; and (3.b) To test for GG interactions among known (e.g. APOE, BIN1, CLU) and novel loci. We will also explore genome-wide GE & GG interactions, and expand our analyses to other midlife environmental covariates when indicated. Aim 4: To functionally characterize the variants identified in Aims 1-3 using (4.a) bioinformatic annotation (4.b) available systemic and brain mRNA, miRNA, methylation data (n~8000 & 750, respectively), (4.c) hippocampal neuronal expression in autopsy brains and (4.d.) Drosophila tau & β-amyloid models. In short, we request modest support for analytic resources to continue a highly productive collaboration that will leverage existing phenotypic and new genetic data worth millions of dollars, as well as established international collaborations, towards a better understanding of AD, one of the biggest health care challenges of this century.